Neuropsychological outcome measures in patients receiving whole brain radiation

This clinical trial is currently actively enrolling patient subjects. At this time, there is currently not adequate data acquired to date to be able to provide a complete analysis. Nevertheless, we have banked patient serum and urine specimens in order to begin biomarker analysis for correlation of to neuropsychological outcomes data in relation to control or progression of disease. As of the end of FY2023, we have closed the study to accrual and are open for data analysis with final results pending.